Pro-tumorigenic roles of a VHL isoform in Clear Cell Renal Cell Carcinoma

Pro-tumorigenic roles of a VHL isoform in Clear Cell Renal Cell Carcinoma.
Kidney cancer or renal cell carcinoma (RCC), is presently the ninth most prevalent
neoplasm in the United States. Its incidence has more than doubled in the developed world over
the past couple decades and is projected to increase in burden worldwide. The most common
subtype of RCC is clear cell RCC (ccRCC), accounting for nearly 80% of all cases. Of note,
ccRCCs lack common genetic abnormalities observed in many other human cancers, thus
impeding the use of more standard treatment regimens by targeted therapies. Greater than 90%
of ccRCC tumors exhibit mutations in the VHL (von Hippel-Lindau) gene. The VHL tumor
suppressor gene encodes three different protein isoforms: pVHL213, pVHL160 and pVHL172.
pVHL172, an isoform lacking exon 2, is a naturally occurring VHL splice variant, that was recently
characterized as lacking tumor suppressor function and having no effect on HIF expression or
function unlike the other VHL isoforms, and effectively promoting tumorigenesis in xenograft
ccRCC mouse models. Here, to better understand the cellular basis VHL172-driven ccRCC, we
propose a set of self-contained studies to investigate paracrine signaling by VHL172 tumor cells.
Based on robust preliminary data, we hypothesize that extracellular vesicles (EVs) derived from
ccRCC tumors play a key role in the induction of pro-tumorigenic phenotypes. EVs harness
select molecular entities—proteins, nucleic acids and lipids, and deliver these cargoes to
recipient cells in the tumor microenvironment. We will test our hypothesis and subsequently
leverage this work to investigate the role of EVs in preclinical models of ccRCC. These
investigations will not only provide new information on EV-mediated intercellular communication
in ccRCC, but also new therapeutic avenues to target patients diagnosed with this kidney
cancer subtype.

Public health relevance
PROJECT NARRATIVE Clear cell renal cell carcinoma (ccRCC), the most common form of kidney cancer, is characterized predominantly by alterations to the VHL gene which often results in the activation of a cellular protein called HIF (hypoxia inducible factor). The altered VHL protein exists in one of three different forms, and it was recently discovered that one of these forms is a potent inducer of ccRCC metastases. Following up on exciting preliminary observations, we will investigate how this tumor-promoting VHL isoform communicates with other cells in the tumor microenvironment, enabling the onset and spread of ccRCC.